The Learning and Educational Attainment of Preterm and At-Risk Infants

PROJECT SUMMARY/ABSTRACT
Infants born prematurely (<37 weeks’ gestation) or at term with congenital anomalies or perinatal conditions
are at increased risk of mortality, neurodevelopmental morbidity, and difficulty with academic achievement.
Specifically, children born preterm show deficits in mathematics, language decoding, and reading
comprehension subskills compared to term children. Academic performance is a useful summary marker for
functional limitations caused by neurodevelopmental impairment and is an intermediate outcome for lifelong
health. Most of our knowledge about the intersection of health and education is derived from studies that rely
on parent recollection. Detailed longitudinal health information tied to educational outcomes is lacking.
Moreover, our knowledge about the impact of participation in programs like High Risk Infant Follow Up (HRIF)
and Early Intervention (EI) on downstream academic achievement is limited. We propose a 5-year study to
examine whether universal early identification of neurodevelopmental disability and equitable and timely
referral to and receipt of appropriate support services can mitigate developmental deficits and improve
academic outcomes. We will leverage the unique partnership in Los Angeles between Kaiser Permanente
Southern California (KPSC), one of the largest integrated health systems, and Los Angeles Unified School
District (LAUSD), the second largest school district in the US. Academic outcomes will be measured using (1)
standardized test scores using the California Assessment of Student Performance and Progress (Smarter
Balance Summative Assessments, English Language Arts and Mathematics components), (2) attendance, (3)
course grades and grade point average, and (4) graduation. We propose to A) merge electronic health and
billing data from KPSC and academic measures from LAUSD. Using this novel data resource; we will B) use
tree-based classification and multi-level growth mixture modelling to compare academic trajectories between
at-risk preterm and term infants and low-risk term counterparts; C) identify predictors of referral and
participation in HRIF and EI and examine mediators and moderators of the association between perinatal risk
and participation in HRIF and EI using logistic and mixed effects negative binomial regression, mediation,
moderation analyses; and D) examine the association between participation in HRIF and EI and academic
outcomes with a matched propensity score analysis and subsequent mixed effects regression models. The
proposed study aligns with the mission of the NIH NICHD to ensure that all children have the chance to
achieve their full potential for productive lives. The association of service use (EI/HRIF) and educational
outcomes identified in this study will inform policy and quality efforts to improve connections between
developmental services, health systems, and school districts.

Public health relevance
PROJECT NARRATIVE Infants born prematurely (<37 weeks’ gestation) or at term with congenital anomalies or perinatal conditions are at increased risk of mortality, neurodevelopmental morbidity, and difficulty with academic achievement. This study will examine whether universal early identification of neurodevelopmental disability and equitable and timely referral to and receipt of appropriate developmental support services (e.g., High Risk Infant Follow Up, Early Intervention) mitigate developmental deficits and improve academic outcomes. Results will inform interventions to optimize preterm and at-risk term infant health and academic outcomes for vulnerable populations by elucidating the roles of developmental support programs.